Preconception and Prenatal Health Impacting Factors and Child Health

Abstract
Childhood obesity and neurodevelopmental impairments have increased in recent decades and are the most
prevalent conditions threatening child’s health and well-being. The consequences of these conditions signify
the need to identify modifiable factors to target for upstream prevention. Emerging evidence suggests that
prenatal exposures to psychological distress, substance use, and lifestyle factors during critical windows of
fetal development may operate to developmentally program childhood obesity and neurodevelopment (ND).
However, few studies have taken a multiple exposure approach to understand the individual and joint
effects of these exposures. In Aim 1 we will examine the role of in utero exposure to psychological distress
and substance use on child growth, adiposity, obesity, and ND and the extent to which prenatal lifestyle factors
and neighborhood factors may mitigate these associations. Further, while maternal diet and physical activity
impact infant growth and adiposity, few studies in diverse populations have assessed mechanistic pathways
and little is known about their impact on ND. We propose the 24-hour movement profile and metabolomics as
our specialized measures of lifestyle, and obesity and ND as our specialized outcomes. The 24-hour
movement profile incorporates the interdependent relationships between device-based measures of physical
activity and sleep during pregnancy to better inform interventions. Metabolomics can elucidate mechanistic
pathways and will be measured repeatedly on the samples collected according to the ECHO protocol (prenatal
blood, cord blood, postnatal child’s blood, and breastmilk). In Aim 2 we will clarify the joint effects of maternal
prenatal dietary patterns and the 24-hour movement and child growth, obesity, and ND and whether
metabolomic signatures prenatally, at birth, and postnatally mediate these associations. For Aims 1 and 2 we
will also examine how associations vary by neighborhood characteristics and infant sex assigned at birth. In
Aim 3 we will maximize recruitment and retention by implementing evidence-based strategies focused on
engaging diverse groups in clinical research and implementing the ECHO Cohort Protocol applying systematic
quality control approaches and best practices. We propose to contribute to the ECHO Program by recruiting a
diverse cohort of 1,800 pregnant individuals from two medical centers at Kaiser Permanente Northern
California serving a diverse population (~70% racial/ethnic minority groups with 50% having a low income), the
conceiving partner, their resulting child, and to follow all of them at multiple visits after the child is born. In Aim
4 we will explore the role of preconception maternal and paternal lifestyle factors on infant birth size to identify
critical time periods to intervene on to prevent upstream risk factors for childhood obesity and ND. All members
of our diverse research team will have equal opportunity to contribute to all aspects of our project and to be
involved in the new ECHO phase. Findings from this study will have important implications for informing
interventions, prevention strategies and policies to ensure optimal health and well-being for all children.

Public health relevance
PROJECT NARRATIVE In this study we propose to contribute to the national ECHO Program by recruiting a diverse cohort of pregnant individuals from two medical centers at Kaiser Permanente Northern California serving a diverse population (~70% racial/ethnic minority groups with 50% having a low income), the conceiving partner, their resulting child, and to follow all of them at multiple visits after the child is born. Individuals who have a second pregnancy during the study period, the conceiving partner and child, will be recruited for a preconception pilot study. We will investigate the impact of maternal prenatal psychological distress, substance use, and lifestyle factors (diet and 24-hour movement) on child obesity and neurodevelopment and identify potential mechanisms and factors that may moderate adverse effects. Findings from this study will have important implications for informing interventions, prevention strategies and policies to ensure optimal health and well- being for all children.